Core B: Developmental

PROJECT SUMMARY/ABSTRACT – DEVELOPMENTAL CORE B
The RUSTBELT CFAR Developmental Core B will stimulate innovative investigator-initiated HIV/AIDS-related
clinical, translational, and fundamental science research activities. The Core serves as the focus for all of the
mentoring and training activities of the CFAR and provides essential financial resources to junior and new HIV
investigators that enable them to demonstrate the feasibility and promise of new research directions. The Core
also provides early investigators with committed and experienced HIV investigators as mentors. The RUSTBELT
CFAR Developmental Core B Core B will be co-directed by two exceptional educators, Dr. Alan D. Levine, Ph.D.,
who joined the CWRU faculty in August 1995 and is a Professor of Molecular Biology and Microbiology and
Graduate Program Director for the Molecular Virology program, and Dr. Nicolas Sluis-Cremer, Ph.D., who joined
the University of Pittsburgh faculty in 2001 and is Associate Chief of Research and Outreach in the Division of
Infectious Diseases, and Professor of Medicine. Importantly, Core B leadership will take advantage of the dual
structure to provide inter-institutional mentoring, increasing objectivity by providing internal reviews from both
institutions, and enhancing the mentoring activities of the Core by providing dual mentorship. The primary
objective of Core B includes the review and award of Developmental (NIH), Catalytic (Institutional) Research
Pilot Grants, Core Awards, and the development and implementation of innovative CFAR mentoring tools for
junior and minority faculty. In this regard, the Aims are to: (1) Conduct responsive Mentored Scientist Pilot Grant
and Catalytic Fund programs that accelerate junior faculty development; (2) Identify, mentor, and support the
next generation of HIV investigators; (3) Provide Minority Training Programs; and (4) Train and provide support
to HIV/AIDS researchers in the responsible conduct, rigor, and reproducibility of ethically sound research.